Vulnerability of SARS- CoV-2 Infection in Lung Cancer Based on Serological Antibody Analyses

As a supplement to our existing U54, we propose that Mount Sinai serve as a coordinating site for aggregating and analyzing demographic, clinical and molecular data from multiple lung cancer studies supported by SeroNet. These studies, from prominent institutions across the country, have been investigating the intersection of lung cancer and SARS-CoV-2 to explore the impact of the combined diseases on patient health, investigate the underlying biology that leads to poor outcomes and understand the effects of lung cancer disease and/or treatments on SARS-CoV-2 vaccination-induced immune responses. To accomplish this goal, we will leverage the considerable expertise and experience of the Mount Sinai Bio-informatics group, led by Joseph Finkelstein, and the data analysis capabilities of our partners at the Vanderbilt Department of Statistics.

Public health relevance
OVERALL: “Vulnerability of SARS-CoV-2 Infection in Lung Cancer Based on Serological Antibody Analyses” Program Director: Fred R. Hirsch, MD, PhD; Co-PI: Adolfo Garcia-Sastre, PhD. PROJECT NARRATIVE The overarching research theme for the Serological Center of Excellence at Mount Sinai, NY is to understand factors contributing to the vulnerability of SARS-CoV-2 infection in patients with lung cancer through serological analysis of antibody response, and to characterize and compare the antibody response to SARS-CoV-2 infection or SARS-CoV-2 vaccines in patients with lung cancer compared to a matched “healthy” control group.